Research Supplement to Promote Diversity: Belvi Bwela (R03EB031495 Parent Award)

PROJECT SUMMARY/ABSTRACT
Every year an estimated 19.4 million children do not receive the set of vaccines recommended by the World
Health Organization, leading to 1.5 million vaccine-preventable deaths.1,2 A majority of undervaccinated children
live in low- and middle-income countries and often have limited access to healthcare.2,3 Nearly 6 million of these
children receive at least one vaccine dose, but remain at risk because they have not completed the full dosing
regimen.4,5 A vaccination method that delivers all doses of a vaccine, or multiple vaccines, in a single injection
would enable children with even one-time access to healthcare to be fully protected from the corresponding
infectious disease. Unfortunately, most controlled-release drug delivery systems exhibit continuous release
kinetics, which is vastly different from traditional soluble vaccines administered in multiple discrete doses over a
course of months. One recent study has described the development of biodegradable microparticle platform with
a polymer shell encapsulating a vaccine-loaded core that exhibits delayed, pulsatile release after a period
determined by the polymer degradation rate.6 By injecting patients with a mixed population of particles with
different degradation rates, vaccine can be released as discrete pulses, thereby mimicking traditional vaccination
schedules known to be safe and effective. Unfortunately, the original microparticle production method negatively
affects antigen stability, requires the use of large-gauge needles, and is low-throughput. This project seeks to
overcome these challenges by preparing microparticles using coaxial electrospraying, a single-step fabrication
process that can produce a single aqueous, vaccine-loaded core surrounded by a shell of polymer. The parent
proposal first aims to create small core-shell microparticles with dense polymeric shells that demonstrate the
delayed, pulsatile release of macromolecules in vitro and in vivo using fluorescently-labeled model molecules
and reporter proteins to assess protein stability within the microparticles. This diversity supplement will expand
the scope of work previously proposed to support the work of Belvi Bwela, a Black female undergraduate student
at Houston Community College, including the encapsulation and stabilization of diphtheria toxoid, a clinically
relevant vaccine. In the original scope of work, this project aimed to encapsulate horseradish peroxidase and
LysoSensor Yellow/Blue-labeled dextran as model compounds which properties that are easy to measure via
enzymatic activity and ratiometric fluorescence. In the expanded scope under this award, Belvi will stabilize
diphteiria toxoid within poly(lactic-co-glycolic acid) microparticles using excipients during particle fabrication and
in vitro release. Ultimately, these particles could serve as a key tool in the fight against infectious disease both
in the developing world where resources are limited and in the developed world, where uninsured children and
rural communities show consistently lower vaccination coverage.7

Public health relevance
PROJECT NARRATIVE Motivated by the 1.5 million vaccine-preventable deaths that occur each year, which are largely due to accessibility challenges in low-resource settings, the parent grant for this proposal seeks to develop a single- injection vaccination platform based on biodegradable microparticles that mimics the antigen exposure profile of current multi-injection vaccination regimens. To do this, we are using coaxial electrospinning to produce microparticles with a core-shell structure, which results in the pulsatile release of antigen after a material- dependent delay. This diversity supplement will support an undergraduate student enrolled at Houston Community College, Belvi Bwela, a Black female, as she investigates the stabilization and encapsulation of diphtheria toxoid in poly(lactic-co-glycolic acid) microparticles.